Novel protein kinase signaling associated with platinum resistance in ovarian cancer

PROJECT SUMMARY
Development of platinum resistance is one of the most important factors contributing to ovarian cancer
recurrence and mortality. In our effort to decipher molecular mechanisms underlying platinum resistance, we
performed a kinome-wide screening on platinum-resistant SK-OV3 ovarian cancer cell line and identified Src-
Related Kinase Lacking C-Terminal Regulatory Tyrosine And N-Terminal Myristylation Sites (SRMS) as a top
platinum resistance regulator. Further analysis of TCGA ovarian cancer dataset revealed that patients with high
SRMS expression responded poorly to platinum-based therapy and had worse overall survival. Since knockdown
of SRMS markedly sensitized p53-deficient ovarian cancer cell lines to platinum while only displayed minor effect
on p53-competent cell lines, we reason that SRMS plays a critical role in platinum resistance of p53-deficient
ovarian cancer. To glean the mechanistic insight into the role of SRMS in platinum resistance, we showed that
SRMS prevents JNK activation, possibly by directly phosphorylating JNKs. JNK signaling pathway is well
established as an essential mediator for apoptosis triggered by cytotoxic agents; our observation that SRMS is
specifically involved in platinum resistance in p53-deficient cells suggests that 1) platinum induces apoptosis in
p53-deficient ovarian cancer cells in a JNK signaling pathway-dependent manner because of the defect in p53
signaling pathway-mediated apoptosis; and 2) SRMS-led inhibition of JNK signaling alleviates platinum-induced
apoptosis and thereby promotes platinum resistance in p53-deficient cells. p53 is uniformly deficient in high
grade serous ovarian cancer (HGSOC). The discovery of SRMS’ prominent role in platinum resistance of p53-
deficient cells indicates that SRMS can be an ideal therapeutic target against platinum resistance in HGSOC. In
our “drug repurposing” screening, we found that PLX4720, a selective inhibitor of B-RafV600E, can potently
inhibit SRMS activity. In this application, we propose 3 specific aims: 1) Characterize molecular mechanisms
underlying SRMS-conferred platinum resistance; 2) Define platinum resistance-relevant events that are
governed by SRMS-JNK signaling; and 3) Investigate the potential of targeting SRMS to augment efficacy of
platinum therapy. The success of this application will uncover molecular mechanism underlying SRMS’ role in
platinum resistance of ovarian cancer. Importantly, we will evaluate SRMS-targeted strategy to overcome
platinum resistance in ovarian cancer.

Public health relevance
PROJECT NARRATIVE Platinum resistance is probably the most important factor contributing to ovarian cancer recurrence and mortality. This application aims to understand the molecular mechanism responsible for platinum resistance of ovarian cancer. This application also aims to develop an effective strategy to overcome platinum resistance by blocking the function of SRMS, a key regulator of platinum resistance in ovarian cancer.